Confidential social network referrals for HIV testing (CONSORT)

UNAIDS set for 2030 the ambitious 95-95-95 target: diagnosing 95% of all persons living with HIV (PWH),
initiating antiretroviral therapy for 95% of those diagnosed, and achieving viral suppression for 95% of those
treated. In Tanzania, a PEPFAR strategy country with an adult HIV prevalence of 4.8%, only 83% of PWH are
aware of their status. More than 200,000 undiagnosed PWH need to test in order to reach the “first 95”.
With the cost-effectiveness of traditional HIV testing approaches declining, we propose to evaluate a novel
application of mobile health (mHealth) technology that leverages the ubiquity of mobile phones and the reach of
social networks to increase rates of HIV testing, especially among higher-risk individuals. Specifically, we will
evaluate the acceptability, efficacy, and cost-effectiveness of automated, confidential, SMS-based HIV testing
referrals, as a means of ‘nudging’ individuals to test. We hypothesize that an automated, confidential referral
system, developed and deployed in the Kilimanjaro Region of Tanzania, will be acceptable to both index clients
and their referrals and that it will be cost-effective for increasing HIV testing rates. Building on existing
relationships with all 25 HIV counseling and testing (HCT) providers in the study area, including 8 HIV care and
treatment centers (CTCs), and using an open-source, low-code, and highly versatile mobile phone-based
appointment reminder and incentive system (mParis), this study will address the following specific aims:
R21 Phase: Aim 1 will conduct qualitative, formative work with (1) HCT providers, (2) HCT clients, (3) PWH who
are in care at CTCs, and (4) social network contacts of HCT and CTC clients, to identify desirable provider- and
client-side characteristics of an SMS-based HIV testing referral system. Aim 2 will adapt our mParis system to
receive phone numbers of HIV testing referrals identified by index clients and autonomously send confidential
HIV testing invitations. Aim 3 will pilot-test the Confidential Social Network Referrals for HIV Testing (CONSORT)
system to collect preliminary data on the system’s acceptability, performance, and potential efficacy.
R33 Phase: Aim 4 will evaluate the acceptability and efficacy of CONSORT in a pragmatic randomized
controlled trial with 400 HCT clients and 200 HIV-infected CTC patients. Arm 1 participants will be offered
confidential SMS referrals and physical invitation cards (“card referrals”) to extend to any of their network
contacts. Arm 2 participants will be offered card referrals alone. The primary outcome will be uptake of HIV
testing. Secondary outcomes include the number of new HIV diagnoses, and the risk correlation within referral
networks. Aim 5 will evaluate the incremental cost-effectiveness of CONSORT+card referrals vs. card referrals
alone. The study will provide estimates of the acceptability, efficacy, and cost-effectiveness of an exceptionally
low-cost intervention for increasing the uptake of HIV testing. More broadly it will develop analytic and mHealth
capacity in Tanzania and inform the development of mobile phone-based chain-referral interventions that can
reach key social networks, are transferrable to other technologies, and can be extended beyond HIV testing.

Public health relevance
HIV testing remains the critical first step in achieving the 95-95-95 goals for HIV/AIDS treatment and prevention, yet testing rates are plateauing and more cost-effective strategies are needed to test higher-risk populations. We propose to leverage the ubiquity of mobile phones and the reach of social networks, to evaluate the efficacy and cost-effectiveness of a novel mHealth intervention, Confidential Social Network Referrals for HIV Testing (CONSORT), for ‘nudging’ high-risk populations to test for HIV. The autonomous, open-source, SMS-based approach can be scaled at minimal cost, is readily extensible to smartphone technologies and social media contexts, and holds significant potential to improve uptake of HIV testing and broadly shift paradigms for engaging social networks to change health-related behaviors.